Sulfane Sulfurs/SO2: Deciphering Redox Environments and Their Implications in Cardio-Protection

Project Summary
Redox imbalances between reactive sulfur species (RSS) and reactive oxygen species (ROS) in cardiac
cells contribute to diseases such as ischemia/reperfusion (MI/R) injury and coronary artery disease. Re-
establishing redox homeostasis has been found to cause strong cardioprotective effects such as vasodilation,
antihypertension and antifibrosis. However, this field lacks clear chemical understandings as to how these
systems work. Our long-term goal is to decipher the complicated redox pathways in various stages of cardiac
cell health and use the information to advance cardiovascular therapies by re-establishing redox homeostasis.
Specifically, this project will develop chemical tools that: 1) controllably mimic complex RSS redox environments
focusing on sulfane sulfurs; and 2) simultaneously detect and utilize ROS to trigger sulfur dioxide (SO2)-related
cellular insights and therapeutic advantages. A variety of these chemical tools will be synthesized, and their
structure activity relationships will be optimized using published procedures. We will then explore their
cardioprotective actions in cell models of MI/R injury and test their viabilities for deciphering complex
cardiovascular redox pathways. We expect promising candidates will be identified for future evaluations in animal
models of MI/R and heart failure. The outlined research will take place in Dr. Ming Xian’s chemical biology
laboratory at Brown University. This research environment contains state-of-the-art tools and equipment for
synthetic chemistry and biology.

Public health relevance
Project Narrative Manipulating small sulfur based signaling molecules such as sulfane sulfurs and sulfur dioxide (SO2) in cardiac cells have been found to fight against heart failure and ischemic stroke, but several fundamental issues must be addressed to advance our understanding of the biology and clinical potential of these methods in the future. In this project, we plan to develop a chemical toolbox of molecules as sulfane sulfur/SO2 donors and use these tools to understand how sulfane sulfurs/SO2 protect cells under oxidative stress. We believe these studies will allow researchers to advance cardiovascular therapies by incorporating sulfur signaling molecules manipulating abilities.